Comparative Effectiveness of Sequential Pharmacotherapeutic Strategies and Virtually Delivered Treatment to Optimize Smoking Cessation

PROJECT SUMMARY
There is a critical need for treatment approaches that conveniently deliver evidence-based interventions of
counseling and pharmacotherapy to a wide range of smokers, and address the complex timeline of cessation
attempt, failure, and re-attempt. The objective of this proposal is to identify the best individualized
pharmacological treatment strategies used for both initial smoking cessation and for rescue therapy among
those who fail to quit or relapse. The trial will use a SMART design (Sequential Multiple Assignment
Randomized Trial) to estimate the comparative effectiveness of (1) an initial 6-week course of either standard
dose varenicline or dual nicotine replacement (our two best performing pharmacotherapies), and (2) among
those smokers who initially fail to quit after the first 6 weeks, to estimate the effects of either continuing on
same medication for another 6 weeks, switching to the medication they did not receive initially, or augmenting
current pharmacotherapy by increasing the dose or adding additional FDA-approved cessation medications. All
treatments will occur via a virtual delivery method ensuring the widest possible application with the fewest
barriers and will include both dynamic pharmacotherapy and counseling delivered in a unified environment to
enhance uptake, effectiveness, and patient experience. The proposed trial will include 2000 adult participants
from throughout Texas who are seeking to quit smoking. Participants will be initially randomly assigned to one
of our two best-performing smoking cessation treatments, either dual nicotine replacement therapy (NRT;
nicotine patch plus lozenge) or varenicline (2 mg/twice daily). After 6 weeks, smoking abstainers will remain on
their current treatment and non-abstainers will be re-randomized to either (a) switch therapies (i.e., receive the
treatment not given in the first 6 weeks), (b) augment their current therapy (change dosage and/or add other
medications, e.g., bupropion), or (c) continue the same medication for 6 more weeks. The treatments will
function as comparators with each other at the selected timepoints specific to each treatment phase. Our
primary outcomes will be biochemically verified (carbon monoxide <6 ppm) continuous smoking abstinence at
Week 6 and at end-of-treatment (EOT) + 30 days. Our secondary outcomes include 6-month abstinence, and
withdrawal, craving, positive and negative affect, and depressive symptoms (anhedonia) Week 6 and at end-
of-treatment (EOT) + 30 days. Our results will inform the patient-provider discussion on the optimal treatment
approach of the future dissemination of our findings. This addresses a critical gap in treating nicotine
dependence because while the majority of smokers relapse within two weeks of an initial cessation attempt
there is little empirical evidence to guide clinicians or patients on the best subsequent treatment to enhance the
likelihood of cessation. Our study sample will be representative of the general population of smokers, drawing
volunteers from diverse community sources as well from disadvantaged populations (Medicaid eligible, rural,
and uninsured).

Public health relevance
PROJECT NARRATIVE Smoking is a significant public health problem that results in over 480,000 premature deaths in the US each year. While many smokers attempt to quit annually, most relapse to smoking within a year, meaning that there is a critical need for better treatments. The objective of this proposal is to estimate the effects of different medication treatment strategies used for both initial smoking cessation and for "rescue therapy" among those who fail to quit or relapse to smoking, which may lead to more personalized smoking cessation treatments.